Donor-specific anti-HIV/SIV immunity mediated by APOBEC3 enzymes

PROJECT SUMMARY
Human APOBEC3 enzymes, particularly APOBEC3D, APOBEC3F, APOBEC3G, and stable haplotypes of
APOBEC3H, can induce G>A mutations in the HIV-1 genome. Often, these mutations, particularly those inflicted
by APOBEC3G, which is a potent anti-HIV enzyme, generate stop codons and lead to HIV-1 inactivation. Studies
have shown that APOBEC3 enzymes can also induce sub-lethal levels of mutations that lead to HIV-1
diversification and drug resistance. Mutations inflicted by different APOBEC3 enzymes and/or different variants
of the same APOBEC3 enzyme vary substantially in terms of both their extent and sequence context. For
example, APOBEC3H haplotype II often induces many G>A mutations. By contrast, APOBEC3H haplotype I,
which is mostly expressed in European and Asian populations, induces little/no changes in the HIV-1 genome.
Our analysis of all reported HIV-1 sequences from ~37,000 patients show that the extent and pattern of viral
hypermutation is highly patient-specific. Additionally, our data indicate that hypermutation patterns are different
between human and nonhuman primate models such as rhesus macaque. We hypothesize that variations in
both APOBEC3 and HIV-1 genes are responsible for the observed differential hypermutation patterns. Our
preliminary data suggest these variations create a complex cascade of patient-specific interactions between HIV-
1 and APOBEC3 enzymes. In support of this hypothesis, we have identified a patient-specific interaction between
APOBEC3H and one of the other APOBEC3 enzymes. This interaction is induced by the HIV-1 protease
processing of APOBEC3H Haplotype II splice variant SV200. Additionally, we have generated data that point to
a significant defect in APOBEC3G mRNA splicing in non-human primates used frequently as HIV-1 models.
Furthermore, our data indicate that variations in multiple HIV-1 proteins, not only Vif, contribute to patient-specific
hypermutation patterns. We propose to combine computational and experimental techniques to determine the
link between these viral and host variations and differential hypermutation profiles.

Public health relevance
PROJECT NARRATIVE Mutation of HIV DNA by human APOBEC3 enzymes can block viral replication or lead to drug resistance depending on the extent and context of mutations. Our data suggest the processes involved are patient-specific. This project aims to identify the underlying genetic variations in both human and HIV DNA using a combination of quantitative and experimental methods.